SELECTIVE SEROTONIN REUPTAKE INHIBITORS (SSRIS) IN LACTATION

1) To determine blood levels of selective serotonin reuptake inhibitors (SSRI) in mothers and their infants. 2) To determine the extent of SSRI excretion into breast milk. 3) To evaluate infant health in mothers taking SSRI medication through questionnaires.